CENTERS OF EXCELLENCE FOR INFLUENZA RESEARCH AND SURVEILLANCE (CEIRS) - EMERGING PATHOGEN PROJECT

Under the CEIRS Network, investigators will collect clinical Zika virus and influenza virus samples from a cohort of pregnant women in Columbia. The study aims to define the impact of influenza and influenza/Zika virus co-infection on influenza seroprevalence in infants.